Contribution of Glutamate Excess and Inflammation to Progressive White Matter Changes in Psychosis

Schizophrenia is a complex disorder associated with subtle white matter abnormalities that progress
over time. Alterations are associated with disease severity across symptom dimensions and worse overall
outcomes, but no strategies exist to attenuate white matter disease progression. This is largely because the
underlying pathophysiological processes remain unknown. Glutamate excess and inflammation may be
contributing factors, but we do not know if there is a period early in the illness where these affect white matter
or if they alter white matter across illness stages.
We propose to use multimodal neuroimaging to study 60 unmedicated first-episode psychosis patients,
60 unmedicated chronic psychosis patients, and 120 matched healthy controls. We will use (1) advanced
diffusion weighted imaging to measure white matter structural integrity, (2) Magnetic Resonance Spectroscopy
to measure glutamatergic and inflammatory markers in white matter, and (3) blood samples to measure
peripheral inflammatory and glutamatergic markers to test the hypothesis that white matter integrity deficits
increase as a function of illness stage and that glutamate excess and inflammation contribute to white matter
pathology.
Identification of factors that contribute to progressive white matter deficits holds the promise to
transform our mechanistic understanding and inform biomarkers for targeted drug development investigating
the potential of glutamatergic or anti-inflammatory agents delaying or attenuating white matter decline in
schizophrenia.

Public health relevance
Public health relevance: Schizophrenia is a complex psychiatric illness associated with subtle changes in white matter that progress over the course of the illness. White matter integrity deficits have been associated with poor response to antipsychotic treatment and worse overall outcomes, but no strategies exist to delay white matter disease progression. Identification of factors that contribute to this process will inform targeted drug development.